EVALUATION OF UNUSUAL FORMS OF INSULIN RESISTANCE

Designed to evaluate patients with unusual forms of in vivo insulin resistance. The underlying pathophysiology will be defined by evaluating endogenous insulin secretion, searching for the presence of hormonal insulin action and immune insulin antagonists, and examining peripheral insulin action in detail.